Exploring the Subthalamic Nucleus Role in Variability Regulation

PROJECT SUMMARY.
Though behavioral variability is often considered to have deleterious effects on performance, it is critical for
identifying new solutions to learn new behaviors and adapt old ones. However, the mechanisms underlying
transitions between high and low states of behavioral variability and the generation of adaptive variability are yet
to be fully understood. Notably, the basal ganglia have been implicated in this regulation, with the Dorsomedial
Striatum (DMS) promoting exploratory, variable behavior, while the Dorsolateral Striatum (DLS) drives
stereotyped actions. Imbalances between DMS and DLS activity can be found across numerous disorders such
as autism, substance use disorders, and obsessive-compulsive disorder. This imbalance results in invariable
and disruptive behavioral patterns with limited therapeutic approaches. However, the neural circuits and
mechanisms through which the DMS-DLS balance and thus behavioral variability is regulated are yet to be fully
understood. Motor skill learning provides rich and continuous readouts of behavioral variability, making it a great
model to study the neural circuits that regulate DMS-DLS mediated variability. Consistent with clinical and basic
scientific findings, our preliminary experiments suggest that the Subthalamic Nucleus (STN) is involved in
behavioral variability regulation. We identified novel projections from the STN to the DMS via the Anterior
Thalamic Nuclei that promote variability during motor skill learning. This finding leads to our hypothesis that the
STN→ATN→DMS pathway regulates motor variability. Given that behavioral variability is not only important
for de novo learning but also for adaptation upon changes in task conditions, we will test if this pathway promotes
variability to adapt learned motor behaviors in Aim 1. In Aim 2, we will test the synaptic mechanisms which
underlie the contributions of this pathway to transitions between high and low states of variability during motor
skill learning. To address these aims, we will combine viral circuit silencing, complex behavioral training
paradigms, machine learning-based behavioral quantification and whole-cell patch clamp electrophysiology.
Successful completion of this proposal will improve our understanding of the regulation of the DMS-DLS balance
and of the resulting behavioral variability, not only in motor skill learning, but across various behaviors.
Importantly, DMS-DLS balance and variability regulation are a critical aspect of learning and behavior and are
severely impaired in a myriad of neurological and neuropsychiatric disorders. Furthermore, our results will
provide insights into novel roles of the STN and into the basal ganglia at large. Finally, this innovative proposal
provides substantial conceptual and technical training opportunities for the PI to build a strong background in
scientific experimentation and data-analysis to fuel the path toward research independence.
.

Public health relevance
PROJECT NARRATIVE. Obsessive compulsive disorder, autism spectrum disorders or substance use disorder affect the neuronal circuitry that regulates behavioral variability. Our research aims to understand these circuits, focusing on a novel, variability-promoting pathway in the basal ganglia. Our insights will help to explain pathological deficits in the various disorders causing invariable behaviors and may aid the development of tailored therapeutics in the future.